Understanding and exploiting novel therapeutic vulnerabilities of RIT1-driven lung cancer

PROJECT SUMMARY/ABSTRACT
Per the FOA, this section is not required. The research supplement proposal does not change the activities of
the parent award.

Public health relevance
PROJECT NARRATIVE Per the FOA, this section is not required. The research supplement proposal does not change the activities of the parent award.